Developmental Funds

ABSTRACT
Overview and Goals: CCSG Developmental Funds are used with the goal of supporting the pursuit of new
scientific opportunities that, when properly selected, enhance UCCC research activities. In the current grant
period, CCSG Developmental Funds were used to develop the Population Health Shared Resource (PHSR) to
integrate population science research across UCCC programs. Since its inception, the PHSR has provided
service to 42 investigators, 81% of whom were UCCC members representing all UCCC programs. The PHSR
provides access to data, tools, and analysts to support multiple areas of research and strategic initiatives
including Community Outreach and Engagement (COE) and Cancer Research Training and Education
Coordination (CRTEC). The PHSR supports the curation and manipulation of national, regional, and local
databases pertaining to cancer surveillance, cancer care delivery and outcomes as well as federal and regional,
surveys describing cancer risk, prevention, and early detection behavior; and it employs analysts with expertise
to employ qualitative and quantitative research methods—study design and implementation that includes focus
groups, key informant interviews, patient-reported measurement selection, and survey development and
implementation. Future Directions: Over the next 5 years UCCC proposes to use CCSG Developmental Funds
to support pilot grants to foster collaborative and exceptional research opportunities that deepen inter and intra-
programmatic collaborations and promote successful, multi-project, sponsored research grant applications.
Projects will be selected based on merit in addition to their potential to leverage existing strengths and capabilities
and translate these into innovations that are likely to lead to external funding and subsequent major advances
in cancer medicine. Use of funds and progress on proposed objectives will be monitored closely to help ensure
success of the efforts to secure three to five new multi-project grants over the next funding period. In summary,
this program will seek to promote team science and leverage institutional strengths and resources to expand the
breadth of UCCC research through the establishment of new collaborative, multi-project grant programs.